DOE Collaboration in support of Expand Data Commons and Data Sharing

? The Center for Cancer Data Harmonization (CCDH) will create a national Cancer Data Ecosystem that will enable participants across the cancer research and care spectrum to contribute, access, combine and analyze diverse data that will enable new discoveries and ultimately reduce the personal and public health burden of cancer. To support this, the CCDH will enable data collection, deposition, harmonization, quality assurance, query, integration, and analytics across an initial set of Cancer Research Data Commons (CRDC) nodes.